Dissection of Addiction Relevant Signal Integration by Cyfip2 through Precise Genome Engineering

PROJECT SUMMARY
Addiction is an enormous economic, personal, and social burden, costing over $600 billion per year in the U.S.
Understanding vulnerability to addiction, and developing effective therapies, requires identifying the genes and
pathways that mediate the addiction process. Our long-term goal is to develop novel genetic models for
addiction-relevant phenotypes, and use these models to characterize the genetic mechanisms of addiction. Here,
we propose to extend our previous work that led to the cloning of a QTL that regulates addiction and the
subsequent identification of Cyfip2 in mouse substrains as a regulator of cocaine acute and sensitized
responses. We and others have since shown that this mutation regulates food reward, nicotine preference, and
alcohol preference (preliminary data). In addition, we have shown that Cyfip2 regulates voluntary self-
administration of cocaine in the IVSA assay, the gold standard in the addiction field. Cyfip2 is a hub for signal
integration from multiple pathways, including the small GTPase RAC1, WIRS domain receptors, and Fragile X
family signaling. We hypothesize that this signal integration by Cyfip2 is critical for reward behaviors. In response
to PAR-19-278, we now propose to use precise genome engineering in mice to generate and functionally validate
5 variants in Cyfip2 (1-2 amino acid substitutions each) that specifically perturb each of these signal integration
events. These mutations are designed using published biochemical data and in consultation with our Co-
Investigator Dr. Chen, who is a leader in Cyfip biophysics and structure. In the R21 phase (Aim 1), we will
leverage the mouse genetics expertise of the Jackson Laboratory to generate by CRISPR/Cas9 a set of 5 Cyfip2
signaling mutants. Specific milestones for progression to the R33 phase are (i) viability of the mutants, since the
knockout of Cyfip2 is postnatal lethal, and (ii) the lack of functional off-target edits. We will then characterize
these mutants comprehensively for cocaine and natural reward behavior (R33, Aim 2). To gain insight into
mechanisms underlying these behaviors, we will determine the biochemical interactome of each mutant in mouse
brain regions using a comprehensive mass spectrometry-based study (R33, Aim 3). The successful completion
of this project will yield 5 preclinical mouse models of addiction transition for the scientific community, as well as
information about specific signaling pathways that are critical for transition to addiction and that can be targeted
for therapy.

Public health relevance
PUBLIC HEALTH RELEVANCE Addiction-related health issues are estimated to cause 590,000 deaths and 40 million illnesses or injuries annually in the U.S. While the progression to addiction is a complex process and depends on many factors, including environment, the propensity to become addicted to drugs of abuse is strongly influenced by genetics. In this project, we will use precise genome editing in mice to identify signaling pathways that mediate addiction behaviors to produce novel preclinical mouse models that could be used to help identify novel therapeutic targets.